Improving Healthcare Efficiency using Real Time Location

DESCRIPTION (provided by applicant): Radianse Inc. (formerly Sentinel Wireless, LLC) has created an automatic, continuous, real-time indoor positioning system (IPS) specifically for the healthcare environment. The IPS is installed on standard networks and is compatible with existing databases, making its deployment simple, inexpensive, and user-friendly. The investigators believe the system will improve the safety and efficiency of healthcare by enabling the monitoring and analysis of patients, staff and clinical process flows. In addition, the system will provide data on equipment utilization, and will reduce the time the clinical staff spend searching for equipment. In Phase I of this SBIR, the researchers determined that the prototype IPS accurately and reliably tracked staff and patients in both space and time. Specifically, the data indicates that the location of tagged staff and patients can be determined to at least the room level and within approximately 30 seconds as compared to the "gold standard" of trained observers recording locations and times. This Phase II SBIR application proposes to demonstrate the IPS installed at MGH results in increased efficiencies in a clinical and research setting as measured by reduced patient waiting times and decreased surgical flow-times. Specifically, based on the successful Phase I results and utilization of the IPS's powerful quantitative platform, Phase II will analyze current process flows in the MGH perisurgical setting. The aims of Phase II are to: - Re-engineer and deploy hardware and software based on clinical feedback for COMMERCIALIZATION. - Quantify the Clinical UTILITY of IPS-on reducing occurrence of delays during surgical care; reducing time spent looking for patients and equipment; on reducing wait time and patient flow time; and on improvement in staff satisfaction. - Quantify the COST-EFFECTIVENESS and ROI in the OR of the Future using the IPS compared with standard OR without IPS. Armed with this solid database, the research community can then tackle the compelling challenges of system inefficiencies and patient care improvements. This research will then allow decision-makers to effect the necessary operational changes and technology purchases to significantly impact cost and patient care. Investigators believe this work will have immediate and dramatic utility in the clinical environment and provide the needed documentation to implement the IPS throughout the hospital.